Rotavirus Reverse Genetics System to Study Viral Pathogenesis and Receptor Interactions

1 Abstract
2 Rotaviruses (RVs) of group A (RVAs) remain an important cause of acute gastroenteritis and mortality in young animals
3 and children. Despite their significance, mechanisms of RVA cell entry, replication and attenuation remain poorly
4 understood indicating a critical need to address these knowledge gaps and design universal control approaches.
5 We have previously conducted comparative sequence analysis that identified two key amino acid substitutions
6 associated with cell culture adaptation and attenuation: D385N in the VP4 of most human and porcine RVA strains and
7 D393H in porcine OSU strain VP4 only. While these or similar mutations were previously suggested to be important for
8 cell culture adaptation/attenuation, their function has not been confirmed experimentally. Using our porcine intestinal
9 enteroid (PIE) system, we have demonstrated that contrasting modes of interactions with the host glycans determine
10 replication efficacy of different RVA strains. OSU replication was uniquely and significantly down-regulated by the
11 removal of terminal sialic acids, while the latter significantly enhanced the replication of a novel porcine G9P[13] strain.
12 OSU is a historic dominant RVA variant characterized by robust in vivo and in vitro replication and consistently
13 associated with diarrheal disease in piglets for several decades, while G9P[13] and G9P[19] are recent, globally
14 emerging RVA variants in swine and humans. It is possible that the latter strains have evolved to acquire some biological
15 advantage allowing for their efficient spread and replication in different hosts. Virulent OSU and G9P[13] strains have
16 unique aa substitutions in the aa positions 385 and 393 of the VP4 hydrophobic loop, which could be a reason for
17 variable interactions with host glycans. Additionally, our recent study demonstrated that the host (PIE) transcriptome
18 response associated with OSU and G9P[13] infections differed drastically altering glycan expression, cholesterol
19 metabolism and innate immune signaling in a strain-specific manner. These findings suggest that evolutionary
20 adaptation of RVAs to the host and host glycans is a critical mechanism allowing for their interspecies (including
21 zoonotic) transmission.
22 Following a previously optimized protocol, our lab has successfully cloned 11 segments of virulent RVA OSU into the
23 pT7 plasmid and rescued infectious virus. We now propose to use this reverse genetics system for in-depth exploration
24 of the molecular mechanisms of RVA virulence, cell attachment and replication. The specific aims to achieve this goal
25 are summarized below:
26 Aim 1: Evaluate if the D385N and D393H substitutions (individually or in combination with other mutations in the OSU
27 VP4) introduced into OSU RGS (ic-virOSU) will confer an attenuated phenotype to the progeny virus (ic-attOSU). Aim
28 2: Evaluate if G9P[13]-like mutations (S385N and D393N) will confer the G9P[13]-like glycan specificity to the progeny
29 virus (ic-G9OSU). Aim 3: To conduct comparative transcriptome analysis of the wild-type (ic-virOSU) and mutant (OSU-
30 att and OSU-G9) OSU variants. Our PIE and Gn pig models as well as the newly established RGS will allow to study
31 how the identified VP4 mutations alter RVA virulence and the selective interactions with host glycans.
32

Public health relevance
Project Narrative. Rotaviruses (RVs) of group A (RVAs) remain an important cause of acute gastroenteritis and mortality in young animals and children; however, the mechanisms of their pathogenesis and replication remain understudied. We propose to conduct translational research to dissect the molecular mechanisms of RVA virulence and host receptor interactions using our innovative, complementary and physiologically relevant models including RVA reverse genetics system, gnotobiotic pigs and porcine small intestinal enteroids.